Innovative Antibiotic Combinations for Hypervirulent Klebsiella pneumoniae

PROJECT SUMMARY/ABSTRACT
Hypervirulent Klebsiella pneumoniae (hvKP) can cause life-threatening infections in otherwise healthy people
that are associated with high mortality rates of up to 40%. In contrast to hvKP, infections caused by classical K.
pneumoniae (cKP) are often restricted to immunocompromised individuals. Increased production of capsular
polysaccharide (CPS) is a primary driver of hypervirulence in KP, which enables the bacteria to evade the host
immune response, including the complement system. Although hvKP have historically remained susceptible to
most antibiotics, multidrug resistance and hypervirulence have recently converged in K. pneumoniae (MDR-
hvKP). Increased CPS production by MDR-hvKP may also directly compromise antibiotics by prohibiting them
from binding to the bacterial outer membrane or by reducing target site penetration. The traditional approach to
select antibiotics for cKP infections is often applied to the treatment of hvKP, focusing primarily on in vitro
susceptibilities. However, this approach fails to consider other unique characteristics of the bacteria, such as
CPS levels, and has never been validated for MDR-hvKP. Our central hypothesis is that excess CPS
expression in MDR-hvKP reduces the activity of certain antibiotics, which can be overcome with targeted therapy
that maximizes bacterial killing and capsule inhibition. In preliminary studies, we generated isogenic strains
that displayed different levels of CPS from their parent MDR-hvKP clinical isolate. Then we evaluated the
response of these strains to a standard-of-care antibiotic (ceftazidime/avibactam) in the hollow fiber infection
model and showed that increased CPS led to diminished antibiotic activity, despite no changes in MIC. We also
found that pre-treatment with subinhibitory concentrations of the polymyxins significantly decreased CPS, which
then sensitized KP to killing by the complement system and ceftazidime/avibactam. Thus, treatment approaches
for MDR-hvKP that combine antibiotics with a CPS-inhibitor adjuvant are highly promising. Leveraging an
innovative approach, this proposal will assess the interaction between antibiotics and CPS to facilitate rational
development of combinations for MDR-hvKP. In Aim 1, we will elucidate the interplay between capsule and
antibiotics. Antibiotics that retain maximal activity in the presence of high CPS production and adjuvants that
decrease CPS will be identified. In Aim 2, we will rationally develop and validate a combination treatment
approach for MDR-hvKP that maximizes synergy between a CPS-inhibitor adjuvant and antibiotic. CRISPR
interference (CRISPRi) will be used to verify that inhibition of the CPS synthesis pathway is a viable target and
that its inhibition can sensitize bacteria to killing by antibiotics and complement. Leading combinations will be
evaluated in a pre-clinical mouse model. This project will generate significant and novel insights into the interplay
between CPS and antibiotic exposure in MDR-hvKP to facilitate rational development of antibiotic therapies.

Public health relevance
NARRATIVE Antibiotic resistance and hypervirulence have recently converged in Klebsiella pneumoniae to create a `superbug' that can cause severe infections associated with high mortality rates. Very few treatment options are available to combat this emerging threat, which has potential to spread among otherwise healthy people in the community. Our proposal will enhance our understanding of the interplay between antibiotic exposure and hypervirulence in order to develop new antibiotic treatment strategies targeting antibiotic-resistant and hypervirulent-K. pneumoniae.